Unraveling Vascular Mediated Immune Exclusion in Melanoma

TITLE: Unraveling Vascular Mediated Immune Exclusion in Melanoma
PROJECT SUMMARY
Melanoma remains the primary cause of skin cancer-related deaths. A significant number of patients show
resistance to checkpoint inhibitors, while others experience disease progression after initial treatment benefits.
A deeper understanding of the mechanisms underlying tumor immune suppression is essential. Effective
immunotherapy not only depends on cancer-specific T cells but also on their direct contact with tumor cells. The
exclusion of immune effector cells, such as cytotoxic T cells, from the tumor parenchyma has been linked to
reduced immunotherapy response. However, the exact biology behind this pattern in the tumor
microenvironment has yet to be fully understood. Recent research emphasizes the potential of targeting the
tumor vasculature to improve tumor immune suppression. The increased vascular leakiness associated with
vascular destabilization has been suggested to hinder immune effector cell infiltration into tumors. Angiopoietin-
2 (ANGPT2), a therapeutic target for many cancers, regulates vascular remodeling by modulating TIE2 receptor
tyrosine kinase signaling in endothelial cells. Our latest study demonstrated that ANGPT2 promotes T-cell
exclusion from tumor cores by causing vascular destabilization at the tumor periphery. This highlights the need
for a comprehensive analysis of vascular regulation in tumor immune exclusion and a deeper understanding of
the molecular mechanism through which ANGPT2 affects T-cell exclusion in melanoma.
In this proposed study, we aim to investigate the vascular determinants of immune exclusion from the
tumor core in melanoma. We plan to elucidate the development of immune exclusions for different immune
cells during melanoma progression and examine the spatial vascular changes in correlation with immune cell
positions (Aim 1). Moreover, we will determine the molecular mechanisms behind ANGPT2-driven T-cell
exclusion in melanoma (Aim 2). This will involve elucidating the relationship between ANGPT2 expression
levels, vascular leakiness, and T-cell exclusion in human melanoma tissues and investigating the effects of
ANGPT2 inhibition on the development and progression of T-cell exclusion using mouse melanoma models.
Employing multi-omics methods, we aim to decipher the molecular mechanisms through which vascular
abnormalities contribute to immune exclusion in the tumor microenvironment of melanoma. Our proposed
study could identify novel targets and biomarkers to address the immune exclusion, potentially enhancing the
effectiveness of existing immunotherapies.

Public health relevance
PROJECT NARRATIVE Immunotherapies have significantly improved melanoma treatment, but drug resistance has limited their therapeutic efficacy. Emerging evidence suggests a fundamental link between vascular abnormalities and immune evasion in the tumor microenvironment whereby vascular destabilization impairs the tumor infiltration of immune cells. In this project, we propose to study the vascular determinants of immune exclusion from the tumor core and the underlying mechanisms in melanoma.